Autophagy, Inflammation and Metabolism (AIM) in Disease Center - Phase 2.

The Autophagy, Inflammation and Metabolism Center (the AIM center) of Biomedical Research Excellence
(CoBRE) at the University of New Mexico Health Science Center (UNM HSC) is a nationally unique center and
a local and international interdisciplinary hub for fundamental and translational research in the areas of
autophagy, inflammation and metabolism. These areas impact an array of health and disease states including
obesity, diabetes, cardiovascular diseases, cancer, infection, autoimmune disorders, neurodegeneration, and
aging. Inflammation and metabolism are at the core of national and global health issues and are central to
health problems in our state such as obesity, driven by disparities as well as by environmental factors and an
aging population. There are few diseases that do not have inflammatory or metabolic components, whereas
autophagy overlaps these areas and provides a unique and novel aspect.
The main accomplishments in Phase I were: (i) the establishment of the center as an entity and as an
internationally recognized intellectual hub; (ii) successful support of mentored PIs (mPIs) evidenced by the
entire initial cohort of mPIs graduating with their independent R01s; (iii) assembly of a significant critical mass
of investigators in the interdisciplinary thematic areas of the center; and (iv) development of a scientific core
with instrumentation enabling rigor and reproducibility. AIM interactive seminars and world-class symposia
drew on the strengths of the local, national, and international scientific community. Based on experiences in
Phase I, the important next step in Phase II is to strengthen the AIM center and build and expand upon these
successes. For Phase II, our long-term goals are to increase the impact and develop a self-sustaining locally,
nationally, and internationally known interdisciplinary center, dedicated to fundamental and translational
research in the areas of autophagy, inflammation and metabolism. Based on experiences from Phase I, we will
strengthen the center in Phase II and ensure its long-term sustainability past phases II and III by implementing
innovative and rigorous strategies. Phase II objectives will be achieved by pursuing the following specific aims:
1. Strengthen the AIM center through further development of its critical mass of investigators in the
interdisciplinary scientific areas of autophagy, inflammation, metabolism, and their intersections.
2. Strengthen the AIM center as a hub for advanced resources complementing other institutional
capabilities and contributing to the center’s long-term sustainability.
3. Strengthen scientific impact and diversity, while paving the path to sustainability of the AIM center at
local, regional, national and international levels and fostering connections with other IDeA programs.

Public health relevance
NARRATIVE (AIM COBRE Overall) Autophagy is a novel, medically highly relevant process functioning in all healthy human cells, which together with the overlapping areas of inflammation and metabolism represents the thematic focus of the proposed Phase II center. Autophagy, inflammation and metabolism have broad medical relevance in cancer, obesity, diabetes, heart disease, Alzheimer’s disease, inflammatory bowel disease, aging, local and dangerous global emerging infections, autoimmune diseases, etc. The Phase II Autophagy, Inflammation and Metabolism (AIM) Center of Biomedical Research Excellence will achieve local impact by enhancing the research base in New Mexico and will represent a nationally important center for the advancement of research on autophagy, inflammation and metabolism in disease, presenting the state of New Mexico and the region with a cutting edge biomedical center of excellence, while giving the nation a resource for the development of new approaches in treating a wide spectrum of diseases.